PFOA targets B cell lipid raft organization and function

PROJECT SUMMARY
Per- and polyfluoroalkyl substances (PFAS) are a group of synthetic organic chemicals that are widely used in
consumer products. Given their chemical stability, PFAS are highly persistent in the environment and are
detected in the water supply, food products, soil, and plants/animals. PFAS can exert immunotoxic effects.
Notably, there is evidence that the legacy PFAS known as perfluorooctanoic acid (PFOA) can impair humoral
immunity, the arm of the immune system that drives antibody production from B cells. A major limitation in the
field is that underlying targets and mechanisms by which PFOA dysregulates humoral immunity are unknown.
Therefore, the objective of this application is to explore new cellular and molecular mechanistic targets of
PFOA. One novel target of PFOA is B cell lipid rafts. Lipid rafts are tightly packed regions of the plasma
membrane made of sphingolipids/phospholipids and cholesterol that serve as platforms for membrane proteins
to efficiently transmit downstream signals. Plasma membrane lipid rafts have a critical role in controlling B cell
activation. Thus, understanding how PFOA exposure leads to dysregulated B cell lipid raft formation would
provide a new mechanistic target by which this compound induces immunotoxicity. Herein, we propose the
central hypothesis that PFOA increases the abundance of unstable plasma membrane lipid rafts of
naïve B cells. Mechanistically, this is driven by PFOA incorporating into lipid rafts and thereby driving lipid raft-
associated lipids into non-raft regions of the plasma membrane. As a consequence, PFOA creates an
impediment toward effective localization of signaling receptors within lipid rafts, which is required for efficient
downstream activation of naïve B cells. To test the hypothesis, we propose two aims that innovatively merge
the fields of humoral immunity, toxicology, and membrane biochemistry/biophysics. Aim 1 will investigate how
PFOA dysregulates the stability and abundance of B cell lipid rafts. Aim 2 will determine how PFOA
dysregulates recruitment of specific receptors into lipid rafts and its functional consequences. Overall, this high
risk/high reward study will establish B cell lipid raft biophysical organization as a new molecular target of
PFOA. These studies will have a sustained impact by opening a new avenue of research focused on
understanding how PFOA and other PFAS control lipid raft organization and function of differing B cell
populations and other key cell types of humoral immunity. Ultimately, this line of research will improve our
understanding of how PFAS exert immunotoxic effects, which can lead to targeted interventions and improved
therapeutics in response to exposure.

Public health relevance
PROJECT NARRATIVE Per- and polyfluoroalkyl substances (PFAS) are a group of synthetic organic chemicals that are highly persistent and linked to immunotoxicity. This application will establish how a select legacy PFAS dysregulates the biophysical organization of B cell lipid rafts and thereby B cell activation, which will provide novel insight on how a specific PFAS can promote immunotoxicity.